Organoids: Engineering Innovative Approaches for Basic and Translational Insight

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Organoids: Engineering Innovative
Approaches for Basic and Translational Insight, organized by Drs. Quinton Smith, Matthias Lütolf and Kelly R.
Stevens, with scientific programming input from Keystone Symposia. The meeting will take place May 11–14,
2025 at the Fairmont Chateau Whistler in Whistler, British Columbia, Canada.
This Keystone Symposia conference explores the biomedical relevance of innovative engineering approaches,
such as 3D bioprinting, synthetic gene networks, programmable biomaterials, and microfluidic systems for
controlling human organoid organization at multiple scales. These approaches hold tremendous potential for
developing novel preclinical drug testing models, disease models, and tissues for regenerative medicine
applications, while also advancing our understanding of basic human biology. Meeting sessions will explore the
latest emerging methods in organoid bioengineering, their applications and utility for advancing scientific
discovery and medical practice. This conference fills a unique need in the scientific community not fulfilled by
other meetings, as it focuses on the intersection of organoid biology and engineering with clinical insights. The
program will address critical gaps in knowledge by bringing together scientists across disciplines in both
academia and industry to challenge current research paradigms and employ transformative approaches and
methods. The goal is to consolidate the field, move it forward, and bridge it with other areas of disease relevance
to enable the greatest impact to science and medicine. Accordingly, this conference will be held jointly with the
Keystone Symposia meeting, Single Cell Biology: Unique Cells to Tissue Ecosystems. Through shared keynote
and joint scientific sessions, poster sessions, and informal social activities, attendees will have an opportunity to
network and share cross-disciplinary insights, which will encourage new collaborations towards understanding
the complex cellular ecosystem that makes up tissues and model organoids.
In addition, this conference will feature among the Keystone Symposia’s 2025 Health Equity Series that seeks
to raise awareness for health disparities in various disease states and initiate discussions on how to rectify health
inequities through scientific research and discovery. As part of this initiative, Keystone Symposia embeds health
equity content across the meeting portfolio by the addition of keynote speakers, workshops and panels that
showcase how scientists are bringing molecular, cellular, and genetic approaches to bear on health equity
research and outcomes. By catalyzing these conversations, and bringing in diverse voices, the aim is to openly
address these issues and foster collaborative and innovative approaches to make health and medicine equally
accessible to all.

Public health relevance
PROJECT NARRATIVE Nearly 90% of new drugs fail human clinical trials, even after completing rigorous pharmaceutical research and costly and time-intensive preclinical studies, which highlights the need for new methods to identify drug candidates with the greatest potential. This Keystone Symposia meeting, Organoids: Engineering Innovative Approaches for Basic and Translational Insight, will highlight emerging technologies in organoid bioengineering, and how these tools are being used to address roadblocks in drug development. The conference will feature the integration of engineering approaches such as genetic engineering, 3D bioprinting, and synthetic hydrogel materials; innovations that promise to advance the field significantly, making this gathering a pivotal event for researchers dedicated to pushing the boundaries of stem cell and organoid science.